International Lowe Syndrome Symposium

PROJECT SUMMARY/ABSTRACT International Lowe Syndrome Symposium; Aguilar (PI)
The International Lowe Syndrome Symposium, scheduled for November 2024 at Purdue University, aims to
transform the landscape of Lowe Syndrome (LS) research and care. This rare genetic disorder, marked by early
mortality and a lack of effective treatments, demands urgent attention and collaborative efforts. The symposium
will unite an international assembly of scientists, clinicians, patients, and families, fostering an inclusive and
multidisciplinary approach to understanding and treating LS.
Our primary goals are to advance scientific research, enhance clinical practices, promote diversity and inclusivity
in medical research, and empower junior investigators in the field of LS. A focus on diversity, equity, and inclusion
ensures broad representation and accessibility, enhancing the symposium's impact across various communities.
The Indiana Clinical and Translational Sciences Institute (Indiana CTSI) infrastructure will be used as a vehicle
to engage a regional and national network, in order to attract a broad range of participants to the symposium.
A central initiative is the "Bring a Junior Colleague" program, supported by R13 funding, which is designed to
engage and develop emerging scientists and clinicians. This includes a “Poster Competition” to encourage
innovative research and provide young investigators with a platform for visibility and professional growth. The
2-day meeting agenda also includes current updates from key investigators, clinicians and patient families
through talks and panel discussions.
The symposium's outcomes are expected to be far-reaching: sharing cutting-edge research, establishing strong
networks for ongoing collaboration, raising public awareness, and identifying new translational opportunities.
Ultimately, the symposium seeks to improve clinical outcomes and enhance the quality of life for those affected
by Lowe Syndrome. In summary, the International Lowe Syndrome Symposium stands as a crucial convergence
point for accelerating progress in LS research and treatment, advocating for patients and families, and cultivating
the next generation of dedicated researchers.

Public health relevance
NARRATIVE International Lowe Syndrome Symposium; Aguilar (PI) The International Lowe Syndrome Symposium at Purdue University directly addresses a critical public health concern by advancing research and clinical knowledge of Lowe Syndrome, a rare but impactful genetic disorder. By fostering interdisciplinary collaboration and promoting diversity in research, the symposium aims to improve diagnostic, therapeutic, and management strategies, enhancing the quality of life for patients and their families. This event also serves as a vital platform for raising awareness and educating the public about Lowe Syndrome, contributing to broader health advocacy and informed community support.